Administrative Core

This Core will provide the infrastructure necessary for achieving the scientific goals of the projects. The Core will be responsible for program administration, interaction with CCHMC, and coordinating meetings between Project leaders and their respective faculty and staff members. The Administrative Core will play an important role in promoting and maintaining optimal communication between investigators, in fiscal administration, and will play a role in coordinating human subjects recruitment and administrative issues for each of the projects. The Administrative Core will ensure that the scientific efforts are coordinated, and that communication between the investigators is optimized. The Core will coordinate monthly meetings of the Project leaders, their respective postdoctoral and clinical fellows, graduate students and technical staff. The Administrative Core will be responsible for organizing an Annual Retreat to be held off campus for the investigators and their extended staff to meet and assess the progress made within each project and to coordinate future experiments. To gain additional perspective, two external advisors will be invited to attend and participate in this annual meeting. Their feedback will be important in assessing progress as well as planning future directions. The Administrative Core will also be involved in administrating and allocating funds. Under Dr. Gurjit K. Khurana Hershey's supervision, Mr. Granger Butler will handle all financial administration of the program project.

Public health relevance
The Administrative Core will provide the infrastructure necessary for achieving the scientific goals of the projects.